A Pilot Investigation of Network-Informed Personalized Treatment for Eating Disorders versus Enhanced Cognitive Behavioral Therapy and Dynamic Mechanisms of Change

PROJECT SUMMARY/ABSTRACT
Eating disorders (EDs) are serious mental illness, with the second highest mortality rate of any
psychiatric disorder and carry high societal, personal, and economic costs. Treatment response
for EDs are suboptimal, with only 50% of adults responding to evidence based treatments and
no evidence-based treatment for anorexia nervosa (AN) or Other Specified Feeding or Eating
Disorder (OSFED) in existence. Part of the reason EDs are so difficult to treat is the high
heterogeneity in symptom presentation, making it difficult to identify what to target in treatment,
as two individuals, even with the same diagnosis, substantially vary. Personalized treatments for
EDs are urgently needed that can improve treatment response and minimize the suffering
associated with these illnesses. Our scientific premise, developed from our past work, is that
treatment personalized based on idiographic models (termed Network Informed Personalized
Treatment; NA-PT) will outperform the current gold-standard treatment (Enhanced Cognitive
Behavioral Therapy: CBT-E). Our study goals are to (1) develop and test the acceptability,
feasibility, and preliminary efficacy of a randomization of NA-PT versus CBT-E and (2) to test if
network-identified precision targets are the mechanism of change. These goals will ultimately
lead to the very first personalized treatment for ED and can be extended to additional
psychiatric illnesses. The proposed research uses highly innovative methods; intensive
longitudinal data collected with mobile technology is combined with state-of-the art idiographic
modeling methods to deliver a virtual, personalized treatment. Specific aims are (1) To collect
preliminary data on the feasibility and acceptability of the randomization of NA-PT (n=40) for
EDs versus CBT-E (n=40), (2) To test the initial clinical efficacy of NA-PT versus CBT-E on
clinical outcomes (e.g., ED symptoms, body mass index, quality of life) and (3) To examine if
changes in NA-identified, precision targets, as well as in dynamic network structure, are
associated with change in clinical outcomes. The proposed research has clinical impact.
Ultimately, this proposal will lead directly to the creation and dissemination of an evidence-
based personalized treatment for EDs, as well as will serve as an exemplar for personalized
treatment development across the entire field of psychiatry.

Public health relevance
PROJECT NARRATIVE This project will collect data on the feasibility, acceptability, efficacy, and target engagement of a personalized treatment for eating disorders. The proposed research has significant public health relevance, as it will directly lead to a highly accessible and deployable personalized treatment that can improve treatment response rates and decrease the high societal burden associated with eating disorders. The proposed research is relevant to NIH’s strategic aim 3.3b, as it will lead to the creation of a personalized treatment consistent with NIH’s precision treatment initiative.